BIOLOGICAL TESTING FACILITY - PRECLINICAL DEVELOPMENT

A Task is required for SRl to maintain a non-human primate animal husbandry facility for contraceptive drug testing. The Biological Testing Facility supports the mission of contraceptive drug development in CDDB, NlCHD, NIH. These activities are currently provided by SRI International.